DNA Binding Dynamics and Oligomerization of Sensors of the PYHIN family in Pattern Recognition

PROJECT SUMMARY/ABSTRACT
Pattern recognition receptors are membrane and cytosolic proteins that alert the organism’s defense
mechanisms by detecting pathogen-associated and danger-associated molecular patterns. The recognition of
pathogenic DNA from bacteria and viruses by DNA sensors triggers an inflammatory response indicating the
danger of infection. Absent in melanoma 2 (AIM2) and interferon-inducible protein 16 (IFI16) are intracellular
pattern recognition receptors that detect pathogenic DNA. Upon DNA binding, AIM2 and IFI16 oligomerize and
recruit other proteins leading to inflammasome assembly. Inflammasomes are multiprotein complexes that
trigger inflammation by activating cytokines in response to danger signals from pathogens or cell dysfunction.
Although inflammation is a fundamental defense mechanism, its dysregulation leads to the onset of several
diseases, including cancer, diabetes, and cardiovascular disorders. The functions of AIM2 and IFI16 and the
signaling pathways they elicit are implicated in autoimmune disorders and drug resistance of certain types of
cancer. Thus, AIM2 and IFI16 are desired targets in anti-inflammatory and anticancer therapies. AIM2 and IFI16
belong to the PYHIN family of multidomain proteins bearing HIN domains for DNA binding and PYD domains for
oligomerization. Evidence suggests that the HIN domains participate in DNA recognition to different extents by
contributing to receptor oligomerization at various levels and engaging in heterotypic HIN-HIN interactions that
could be involved in receptor inhibition. Our laboratory has reported key mechanistic information on the assembly
of AIM2 on DNA at the single-molecule level using optical traps combined with confocal fluorescence
microscopy. We showed that the binding of AIM2 to DNA promotes AIM2 self-association into oligomers of
different sizes. Our real-time data on AIM2-DNA binding allowed us to establish that single AIM2 molecules and
oligomers do not significantly diffuse along the DNA. We are extending these studies to IFI16 HIN domains,
revealing they also oligomerize on DNA. In contrast to AIM2, IFI16 HIN domains demonstrate significant mobility.
We have corroborated these results with biochemical methods showing that IFI16-HIN oligomerization on
double- and single-stranded DNA depends on DNA length. In this project, we will demonstrate that individual
HIN domains play different roles in molecular pattern recognition based on their different diffusivity and
oligomerization on DNA and their capability to engage in heterotypic HIN-HIN interactions. We will use optical
traps and confocal fluorescence microscopy to establish relationships between mobility, oligomerization, and
HIN-DNA complex survival time. In addition, we will determine the stoichiometry of HIN-DNA complexes as a
function of DNA length and identify heterotypic HIN-HIN interactions by biochemical methods. The successful
outcome of this project will define the impact of oligomerization and binding dynamics on the survival of HIN-
DNA complexes, which is key for subsequent signaling steps of innate immunity and inflammatory processes.

Public health relevance
PROJECT NARRATIVE The human body relies on specialized proteins (pattern recognition receptors) capable of detecting pathogens to alert our defense mechanisms by eliciting inflammatory and immune responses. The dysregulation of pattern recognition receptors is relevant to human health as it leads to severe inflammation, which in turn is conducive to a broad range of diseases, including cancer, diabetes, cardiovascular, and neurodegenerative disorders. In this proposal, we will dissect fundamental factors in pathogenic DNA recognition at the molecular level, including receptor self-association, DNA binding dynamics, and survival of DNA-receptor complexes, with the ultimate goal of providing key information relevant to the design of therapeutic interventions.